Transcriptional control of gut epithelial homeostasis and regeneration

Project Description
Inflammation, cancer, and other common disorders of the digestive tract reflect dysfunction in the
dynamics of intestinal stem (ISC) and other crypt cells. Improved treatments require a better understanding
of how Lgr5+ ISC, progenitor, and differentiated cell states may be promoted or disfavored. Recent findings
substantially revise the traditional view that movement from ISC  intestinal bipotential progenitor (IBP) 
transit-amplifying (TA) cells is strictly linear and unidirectional. Instead, crypts appear to be highly dynamic
units, where cells interconvert with surprising ease and various dedifferentiating progenitors are the main
source of crypt regeneration after ISC injury. One gene particularly implicated in ISC functions encodes
the Wnt-dependent transcription factor (TF) ASCL2. In the last funding period, we examined chromatin
states critically in diverse resting crypt populations and in cells captured in the act of dedifferentiating into
ISC; those findings made notable mechanistic contributions toward the emerging view of crypt dynamics in
relation to chromatin states. To build on the advances, we engineered a new mouse Ascl2 allele to flag its
expression with a fluorescent label, identify binding sites by epitope-tagged chromatin immunoprecipitation
(ChIP), and delete the gene at will. Contrary to a published report, we find that Ascl2 is dispensable for
resting ISC function. It is, however, essential (a) for crypts to replenish Lgr5+ ISC when the native pool is
damaged, and (b) for cells with constitutive Wnt activity (Apc-/-) to form sizable tumors. Moreover, both
Ascl2-/- and Ascl2+/- ISC differentiate prematurely into IBP, suggesting that ASCL2 levels dictate cell exit
from the ISC compartment. These animal models and preliminary data provide the background and tools to
ask fundamental mechanistic questions about the determinants of ISC vs. IBP vs. TA identity. Aim 1
examines wild-type and Ascl2-/- ISC and isolated regenerating crypt cells using state-of-the-art epigenome
methods to identify crucial, ASCL2-dependent steps that favor the ISC state in native Lgr5+ and
dedifferentiating cells. We will also ask which crypt populations can dedifferentiate and, in organoid
cultures, which extrinsic signals promote rapid ASCL2-dependent crypt regeneration. Aim 2 tackles the
problem that dedifferentiation of tumor cells limits the potential of ablating tumor-initiating (TIC, `cancer
stem') cells as a treatment for cancer. We will test the hypotheses that ASCL2 drives distinct transcriptional
programs in tumor and normal ISC, and that it is required to maintain tumors by dedifferentiation when TIC
are killed. These studies could have important future clinical applications. Aim 3 tests the hypothesis that
Lgr5+ cells in the crypt base are intrinsically poised at the junction between ISC and IBP states, and that
ASCL2 levels determine ISC vs IBP identity. This original and cohesive investigation of labile crypt cell
states, along with their TF and chromatin underpinnings, will yield fundamental new insights into cell
decision mechanisms that are highly relevant to human disease.

Public health relevance
Project Narrative: Accurate, life-long replenishment of the intestinal lining relies on the activity of intestinal stem cells (ISCs), is essential for health, and is compromised in common disorders such as Inflammatory Bowel Disease and colorectal cancer. One surprising recent discovery is that when ISCs are damaged or killed, many different daughter cells can restore tissue integrity by converting back (“dedifferentiating”) into ISCs. This project seeks to understand how cells implement this extraordinary facility, which has important implications for intestinal repair in disease states and possibly for novel ways to reverse malignant behaviors in cancer.